Program for Resistance, Immunology, Surveillance & Modeling of Malaria in Uganda (PRISM) Renewal

Summary/Abstract
Malaria remains one of the most important global health challenges, with an estimated 247 million cases and
619,000 deaths in 2021, of which 95% of cases and 96% of deaths were in the WHO Africa region. The scale
up of proven control interventions resulted in significant reductions in the burden of malaria following the turn of
the century. However, since 2015 progress has stalled and even reversed course in some of the highest
burden countries of Africa. Indeed, a myriad of challenges, including the spread of insecticide resistance,
changes in vector composition and behavior, the emergence of artemisinin partial resistance, and the COVID-
19 pandemic have created a precarious situation. Our program called “PRISM” has been based in Uganda,
representing the East African region for the International Centers of Excellence for Malaria Research network.
Uganda is emblematic of the challenges faced by high burden countries, where routine surveillance systems
are inadequate to assess trends in the burden of malaria or to monitor the impact of control interventions.
Through PRISM we have implemented a comprehensive malaria surveillance program including enhanced
health facility-based surveillance and detailed longitudinal studies. Complementary laboratory-based studies
include surveillance for markers of antimalarial drug and insecticide resistance and serologic measures of
malaria exposure. These studies have greatly improved our understanding of the epidemiology of malaria in
Uganda and of the impact of control interventions. In this renewal application we propose to continue key
components of our health facility and community-based malaria surveillance to strategically focus on
quantifying the impact of malaria control interventions, working in close collaboration with our partners at the
Uganda National Malaria Control Division (NMCD). We will utilize specimens collected from our surveillance
system to generate genomic and serologic data to address key questions about malaria epidemiology,
transmission, diagnostics, and antimalarial drug and insecticide resistance. The central theme of our program
will be to improve malaria surveillance to better assess the impact of malaria control interventions and guide
evidence-based utilization of existing and novel interventions to reduce the malaria burden using an adaptive
approach. The program will consist of three research projects linked together in an integrated manner to
maximize scientific discovery. Research Project 1 (Surveillance and Impact Evaluation Project) will utilize
health facility and community-based malaria surveillance data from sites with varied transmission intensity and
control interventions to monitor trends, estimate the impact of interventions, and provide clinical data and
specimens for our other research projects. Research Project 2 (Resistance Project) we will characterize the
evolution of genotypic markers of drug and insecticide resistance and assess the impacts of resistance on
malaria transmission. Research Project 3 (Molecular Epidemiology Project) will characterize key parasite and
vector genomic traits and human serological responses.

Public health relevance
Project Narrative Progress in reducing the burden of malaria has recently stalled and even reversed course in some of the highest burden countries of Africa, including Uganda. New strategies are urgently needed to respond to emerging threats including the use of multiple sources of data to better understand malaria risk at the sub- national level and target interventions. The central theme of our program will be to improve malaria surveillance to better assess the impact of malaria control interventions and guide evidence-based utilization of interventions to reduce the malaria burden using an adaptive approach.